Plasma brain-derived tau: a novel Alzheimer’s disease-type neurodegeneration biomarker with potential to complete the AT(N) scheme in blood

While the Amyloid(A)/Tau(T)/Neurodegeneration(N) framework has been validated against
neuropathology, cerebrospinal fluid (CSF) and neuroimaging biomarkers, its implementation in
blood is incomplete. We now have high-performance plasma A and T markers that become
abnormal according to AD pathophysiology. However, the current N marker – neurofilament light
(NfL) – is a non-disease-specific indicator of neurodegeneration/neuronal injury. Moreover,
plasma total-tau (t-tau) has large overlaps between diagnostic groups and does not correlate with
CSF t-tau. We have developed and validated a novel AD-type neurodegeneration biomarker
(referred to as brain-derived tau [BD-tau]) with capacity to complete the AT(N) framework in blood.
Our overall goal is to perform a large-scale clinical and pathophysiological validation of plasma
BD-tau. We will leverage five longitudinal, already existing, racially/ethnically diverse sporadic AD
cohorts (n = 2,594) with clinical, in vivo, and post-mortem evaluations to answer the following
specific aims: Aim 1. To compare associations of plasma BD-tau, NfL and t-tau with clinical
diagnosis of AD and longitudinal cognitive change; Aim 2. To compare AT(N) profiles and
associations for plasma BD-tau vs. NfL and t-tau; Aim 3. To compare the (added)
diagnostic value of plasma BD-tau vs. NfL and t-tau for autopsy confirmation of AD; and
Exploratory Aim 4: To compare performances of plasma BD-tau vs. NfL and t-tau in
different racial/ethnic groups. If proven, BD-tau will complete the AT(N) scheme in blood,
improving diagnostic and prognostic accuracies and confidence, as well as the prediction of
longitudinal cognitive change that are directly translatable to anti-AD clinical trials.

Public health relevance
The AT(N) framework has been validated to reflect AD pathophysiology, and operationalized postmortem and antemortem, with critical contributions from our group, however, its translation to blood remains challenging. While plasma Aβ42/Aβ40 and p-tau address the A and T aspects of the AT(N) framework in blood, an AD-specific N marker is lacking because neither plasma t-tau nor NfL – the current N markers in blood – predicts AD pathology at autopsy, associates with plaque and tangle pathology, or differentiates AD from non-ADs. The public health significance of the proposed research is that it will improve the specificity and accuracy of blood biomarkers by enabling a complete set of A, T, and N markers that that are specific to AD pathophysiology, and also validated in diverse communities including those most impacted by AD but have received the least resources in AD research and care.